Pathophysiology of Adult T-cell leukemia/lymphoma

T-cell acute lymphoblastic leukemia (T-ALL) is an aggressive cancer in adult patients. Adult T-ALL is frequently
the Early T-cell Precursor (ETP-ALL) subtype that manifests with treatment-resistance and high risk of relapse.
The demographic of adult T-ALL matches that of young Veterans so this grant has the potential to impact the
diagnosis and care of this Veteran population. Like many aggressive human leukemias and lymphomas, T-ALL
can be put into remission by cytotoxic chemotherapy yet the majority of patients relapse. We have learned from
our studies that targeted therapies against mutant oncogenes stimulating proliferation, like JAK1/3, also induce
responses that are short lived. In these cancers, the high rate of complete remission followed by the high rate of
relapse is explained by the presence of treatment-resistant leukemia-initiating cells (LIC) that have hematopoietic
stem cell-like features. The LIC lie dormant and survive during chemotherapy and then expand after remission-
induction. Hence, targeting this LIC population is crucial to achieving cures. LIM domain Only-2 (LMO2) is a
major driver oncogene in T-ALL, where it confers stem cell characteristics upon normal T-cell progenitor cells.
Targeting LMO2-induced T-ALL LIC will involve targeting the LMO2 complex. Towards this end, we have
biochemically characterized the LMO2 complex to understand its structure and function. In preliminary data, we
show that LMO2’s oncogenic function requires it to act as part of a multisubunit macromolecular complex.
LMO2’s direct binding partners include the basic helix-loop-helix proteins, TAL1 or LYL1, and the GATA motif
binding proteins GATA1, 2, and 3. We discovered that LMO2’s ability to induce T-ALL is exquisitely dependent
upon another protein, LIM domain binding 1 (LDB1), to which LMO2 is constitutively bound. LDB1 has its own
interaction partners, namely the Single Stranded Binding Proteins SSBP1-4. Importantly, LMO2 complex
formation confers protein stability. In the course of our studies, we made observations that could hold the key to
better understanding LMO2’s induction of the LIC and to better targeting of the LMO2 complex. Although LMO2’s
induction of the LIC in mouse models has been extensively studied, this has not been translated to human cells.
We hypothesize that LIC properties are conferred by the LMO2 complex upon T-cell progenitor cells.
Furthermore, our proteomic studies reveal a panoply of paralogous proteins in the LMO2 complex but we do not
believe they are functionally equivalent. We hypothesize unique functional roles for the various paralogues of
the LMO2 complex, TAL1 v. LYL1, GATA factors 1-3, and SSBP factors 2 v. 3. We will investigate this in a novel
human modeling system. Lastly, we hypothesize that targeted therapy against LMO2 will involve perturbation of
the LMO2 complex. The Specific Aims of this grant will advance our understanding of how LMO2 functions and
how it may be targeted in these aggressive leukemias.

Public health relevance
T-cell acute lymphoblastic leukemia (T-ALL) affects both children and adults. T-ALL shows a male predominance and is found in adult patients aged 20-60. This epidemiologic pattern closely fits the demographic of young Veterans. Although T-ALL is an uncommon cancer among Veterans, it has aggressive clinical features that make it difficult to treat. This grant proposes to study adult T-ALL from the perspective of the LMO2 oncogene, which is universally expressed in ETP-ALL and immature T-ALL, both are poor prognosis subtypes that are present in adult T-ALL patients. The specific aims of this grant address the unmet need of therapeutics for ETP and adult T-ALL through novel cutting-edge approaches. Since the LMO2 oncogene may very well be involved in other leukemias that affect Veterans, the findings from the proposed studies have the potential to be applied to multiple other cancers.